Data Detectives: Using Real Data to Solve Real Community Health Problems

Revised Abstract
Data sciences represent key advances for multiple areas of discovery in science and health. To continue to produce future scientists with expertise in biomedical and data sciences, we hypothesize that providing students with a curriculum focused on using population-level Big Data for community health needs assessment, planning, analysis, evaluation, and application will improve students’ understanding of the importance of science and Big Data beyond the laboratory or classroom. We envision such a program will engage students by making science more applicable. To address the gaps in the literature and the lack of practical tools to teach students how to both use and apply population-based Big Data, we will pursue the following Specific Aims for our new SEPA program, Data Detectives: Using Real Data to Solve Real Community Health Problems: 1) to implement a novel, problem-based, experiential learning curriculum to teach middle school students science and mathematics content and data science principles with direct application to community-based health issues; 2) to conduct a robust evaluation of the program with measures of student knowledge, attitudes, self- efficacy, and pursuit of future STEM careers; and 3) to prepare for broad dissemination of the curriculum throughout Georgia and the US. This program will provide the foundation for K-12 students to use real data to solve real problems focusing on addressing health in communities. The proposed SEPA program meets three NIGMS priority areas: A) teaching students to use Big Data instills needed computational and quantitative skills; B) the curriculum demonstrates applicability to the real world by using problem-based learning (PBL) to challenge students to solve real community-level health problems using real population-based data; and C) the program follows a robust mixed methods evaluation plan to measure both quantitative and qualitative outcomes. The Research Education Program plan addresses the three Specific Aims and includes rationale for adaptation of the Problem-Based Learning model; a detailed curriculum aligned with MS NGSS; clear identification of population-based datasets to be used; and explicit examples of PBL scenarios that require application of data sciences. The Dissemination Plan will share the curriculum and materials across Georgia and the U.S. The ability to evaluate this curriculum in a cohort of middle school students, to measure its effect on potential for future STEM careers, and then ultimately disseminate it nationally to schools and informal science education programs, has the capacity to impact K-12 educational approaches and future data scientists in new and important ways.

Public health relevance
The future STEM and biomedical workforce will benefit from additional expertise and focus in data science. This novel, experiential problem-based learning approach uses population-based Big Data to engage middle school students to apply real data to solve real community health issues. The goal of the Data Detectives SEPA program is to develop and evaluate an informal science education curriculum focused on data sciences and application to community health issues.